Progressive states of cell-cycle withdrawal

Project Summary
Senescence is the process by which a cell permanently stops proliferating due to cellular aging
or damage but does not die. Induction of senescence is often desirable during cancer treatment
to prevent the proliferation of aberrant cells, but it also impedes cellular function and
regenerative capacity as we age. The study of cellular senescence is hindered by the fact that
senescence is difficult to distinguish from other states of cell-cycle withdrawal such as
quiescence, a transient cellular resting state. This is because quiescence and senescence are
defined by overlapping molecular markers and because these cell-cycle transitions occur
heterogeneously from cell to cell. Despite obvious medical relevance, it is unclear whether
senescence and quiescence are truly distinct states. Here we propose to test the hypothesis
that senescence and quiescence exist on a continuum of cell-cycle withdrawal where the
probability of cell-cycle re-entry steadily declines toward zero as cells become senescent.
We will leverage our unique expertise in long-term, time-lapse microscopy, automated single-
cell tracking, and the development of sensors for cell-cycle progression and cell-cycle
withdrawal to unveil gradations of cell-cycle withdrawal that are invisible by standard bulk
approaches. Our specific aims are 1) To determine the predictive power of prevailing
senescence markers as binary markers of senescence and as graded markers of quiescence
depth, 2) To determine at the transcriptomic level whether quiescence and senescence are
distinct states or part of a continuum of cell-cycle withdrawal, and 3) To the identify the DNA
damage and telomere features that predict permanent cell-cycle withdrawal as cells age toward
replicative senescence.
If successful, this work will improve our ability to define molecularly the state of senescence and
will generate new fundamental knowledge about the onset of senescence. Our work could
improve the ability to predict tumor relapse after cancer therapy, help quantify a cell’s
physiological age and reproductive potential, identify ways to rejuvenate aged cells, and
improve the safety of senolytic drugs that eliminate senescent cells.

Public health relevance
Project Narrative A fundamental question in biology is why cells age and permanently cease to divide, a process called cellular senescence. The proposed project uses modern, single-cell technologies to characterize the onset of senescence, to determine how senescence relates to a transient state of cell-cycle withdrawal called quiescence, and to develop a molecular framework that can predict a cell’s likelihood of re-entering the cell cycle and its physiological age. Since chronological age is the major predictor for most human diseases, the proposed work could impact the treatment of multiple diseases by developing treatments to slow or even reverse human aging.